MALDI-TOF FOR PROTEIN CHEMISTRY APPLICATIONS

This proposal describes the need in ongoing biomedical research of a rapid, sensitive and accurate Matrix-Assisted Laser Desorption Time-Of- Flight mass spectrometer, (MALDI-TOF) with delayed ion extraction and an improved detector in a shared-used facility in the Department of Biochemistry at the University of Washington Medical School. The facility has leased and earlier model of the instrument for three years and determined that it has technical advantages for certain studies that complement the utility of the Electrospray triple quadrupole instrument that was purchased for the same laboratory by a SIG in 1991. The new MALDI-TOF will extend service to a diverse user group of 15-45 principle investigators (in more than 8 Departments) with more than 22 NIH- supported research programs. Targets of these studies range from large proteins and their post-translational modifications to smaller peptides, drugs and metabolites. No other MALDI-TOF is available at the University to serve these needs.